Expanding a culturally relevant model of sexual minority tobacco use: the impact of identity

PROJECT SUMMARY
The overall goal of this proposal is to provide the training, career development, and mentorship that will result in
Dr. Hinds’ ability to integrate the bodies of research surrounding sexual minority (SM) identity development with
tobacco use across the lifespan, expanding and improving upon culturally-relevant conceptual models that
explain SM tobacco use. Dr. Hinds is a postdoctoral research fellow and Adjunct Assistant Professor at the Steve
Hicks School of Social work at The University of Texas at Austin. Dr. Hinds’ research portfolio has focused on
describing and explaining the tobacco use disparities of sexual and gender minority (SGM) young adults. Dr.
Hinds’ long term career goal is to be a faculty member at a top-tier research university with a portfolio of
independent, community-engaged collaborative research aimed at eliminating SGM tobacco and substance use
disparities. Dr. Hinds completed a 2-year postdoctoral research fellowship funded through the National Heart,
Lung, and Blood Institute (NHLBI), focused on promoting health equity in cardiovascular disease
(T32HL140290). Dr. Hinds completed graduate training in Tobacco Regulatory Science and received her PhD
in Health Behavior and Health Education. In the current five-year proposal, Dr. Hinds outlines three training goals
that are critical to expanding her skill set as an SM-focused tobacco researcher, to be addressed through
coursework, seminars, directed readings, and mentored meetings: 1) content training in SM identity development
and tobacco use across the lifespan, 2) methodological training in psychometrics and survey instrument
development, and 3) data analysis training in order to test and refine a comprehensive model of SM tobacco use
that includes elements of SM identity, measured multidimensionally. Dr. Hinds has assembled a strong
mentoring team of highly successful, multidisciplinary experts who can each advise on multiple training goals
and research aims, where Dr. Hinds will comprehensively examine the SM identity-related factors and
dimensions that are linked to both increased and decreased risk for tobacco use and yield the following three
primary outcomes: Aim 1) novel findings into the association between identity dimensions and milestones with
tobacco use, based on mixed method secondary data analysis of two of the most prominent SM-focused studies
ever conducted in the U.S.; Aim 2) a novel survey instrument assessing the phenomenon of SM identity
management behaviors, and Aim 3) an updated and comprehensive conceptual model of SM tobacco use, that
integrates the identity elements of dimensions, milestones, and identity management behaviors as explanatory
mechanisms, alongside minority stress, in explaining unique determinants of SM tobacco use. Ultimately,
findings from this project will improve our understanding of the etiology of SM tobacco use disparities, and inform
an R01 proposal that will identify avenues for identity-affirming initiatives designed to reduce SM tobacco use.

Public health relevance
PROJECT NARRATIVE Between two and five times as many SM people smoke or use tobacco as their heterosexual counterparts, resulting in disproportionate amounts of tobacco-related morbidity and mortality in SM communities. NIH has designated SM people a health disparity population, yet their tobacco disparities are persisting, and in some cases, worsening. Advancing our understanding of the etiology of SM tobacco use disparities and the potential protective effect of SM identity elements would help identify avenues for future targeted and tailored interventions, improving SM tobacco use disparities and improving SM health.